Multi-isotope Hybrid PET/CT Imaging of Peripheral Artery Disease in Diabetes

Patients with diabetes mellitus (DM) remain at high risk for the development of significant co-morbidities,
specifically those associated with autonomic dysfunction, peripheral artery disease (PAD), and cardiovascular
complications with a 2 to 10-fold higher mortality rate. PAD may manifest as stress induced leg pain
(claudication) due to vascular insufficiency or critical limb ischemia (CLI) as the most severe manifestation of
lower extremity PAD characterized by lower limb ischemic rest pain and/or the presence of tissue loss. The
sympathetic nervous system plays a critical role in the normal autoregulation of the vasculature, and loss of
vasomotor control is responsible for postural hypotension but also for the remarkable increase of peripheral
blood flow and arteriovenous shunting in the neuropathic diabetic foot. Therefore, sympathetic denervation
increases blood flow, as it results in vasodilation and non-nutritive, arterio-venous shunting. Sympathetic
denervation may cause structural damage to peripheral arteries resulting in degeneration of arterial medial
smooth muscle with subsequent medial artery calcification (MAC) a feature of diabetic neuropathy. Positron
emission tomography (PET) imaging with 82Rb provides high-sensitivity and high-resolution images for
quantification of absolute flow, while a 18F-labeled norepinephrine analog (18F-LMI1195) provides information
about sympathetic activity. This project will optimize and apply dual isotope (82Rb/18F-LMI1195) hybrid PET/CT
imaging for evaluation of lower extremity flow and denervation and vascular calcification in pre-clinical models
of PAD and in patients with DM and PAD. We propose a clinical imaging sub-studies of two active multi-center
observational registry called SCOPE-CLI and PORTRAIT, which were designed to phenotype patients with CLI
and claudication, respectively. These registries collect observational data on treatment patterns, and other
outcomes that are relevant to patients with DM and PAD. In Aim 1, our hybrid PET/CT imaging approach will
be optimized using a porcine model of hindlimb ischemia in the presence and absence of an acute peripheral
nerve block. These studies will establish methods for evaluation of skeletal muscle rest and stress flow and
flow heterogeneity. Aim 2 will apply dual isotope PET/CT imaging for quantification of acute and chronic
changes in regional flow and flow reserve before and after regional denervation of the lower extremities in
relation to development of MAC in a chronic rabbit model of peripheral denervation. In Aim 3 we will translate
this approach to patients with DM and a spectrum of PAD disease severity to evaluate the prognostic value of
hybrid PET/CT imaging of lower extremity for predicting progression of MAC, rates of amputation, and major
adverse cardiovascular events. The proposed multi-isotope PET/CT imaging of lower extremity flow and
innervation developed and applied in this project in conjunction with imaging of vascular calcifications will
characterize the pathophysiology of autonomic dysfunction in critical limb ischemia and this information may
lead to a paradigm change in the evaluation and long-term management of patients with DM and PAD.

Public health relevance
Diabetes mellitus (DM) is associated with significant co-morbidities, specifically those associated with nervous system dysfunction, including increased risk for peripheral artery disease (PAD), and cardiovascular complications. This project will optimize and apply dual isotope hybrid non-invasive imaging approach for evaluation of lower extremity flow, peripheral nerve activity, and vascular calcification in pre-clinical models of PAD and in patients with DM and a spectrum of PAD severity. The proposed multi-isotope imaging of lower extremity flow and nerve activity developed and applied in this project in conjunction with imaging of calcifications of the arteries will characterize the pathophysiology of nerve dysfunction in PAD and this information may lead to a paradigm change in the evaluation and long-term management of patients with DM and PAD.